OPEN LABELED SINGLE CENTER COMPARISON OF SANDIMUNE AND GENERIC CYCLOSPORINE

To compare the bioavailability of Sandimmune liquid to a generic cyclosporine liquid formulation. The patient will receive Sandimmune for one week then get a pharmacokinetic assessment. The patient then will convert to the same milligram dose of generic cyclosporine then have a pharmacokinetic assessment. After this the patient will return to the initial Sandimmune liquid, after one week a final pharmacokinetic assessment.